Deciphering the immunoregulatory network governing antigen presenting myeloid cells

SUMMARY
The goal of this administrative supplement for the parent award R35GM145290 is to purchase a flow
cytometric analyzer system for high-throughput automated sample acquisition and analysis. The equipment will
allow measurement of multiple properties within various investigated immune cell subsets. Readout indices
include assessment of cell population frequencies, proliferation capacities, variances in lineage commitment
and differentiation, altered molecular signaling activities and changes in functional outcomes in response to
pathogen challenges, among other measurements. Briefly, dendritic cells (DC) are responsible for directing T
cell responses and macrophages important for modulating tissue inflammation. A hallmark of these immune
cells is their inherent plasticity in gene expression profiles to govern immunity vs. tolerance. However, much
remains unknown regarding the complex molecular networks that collectively govern hematopoiesis,
inflammation and antigen presentation. Incomplete understanding presents major obstacles to delineating their
underlying roles in health and disease, which has also hindered success in developing effective
immunotherapies. The long-term goal of the proposed research is to determine how pivotal immunoregulatory
proteins govern DC and macrophage differentiation and immune responses in steady-state vs. disease
settings. Acquisition of a flow cytometric analyzer with a universal loader will allow the laboratory to engage in
high-throughput automated sample acquisition to assess multiple indices within samples employing 96- and
384-well plates. Knowledge gained in our studies, with the chief readout instrument being flow cytometric
analysis, will fill key gaps in our understanding of DC and macrophage biology and provide important insights
into the molecular networks governing immunity and tolerance.

Public health relevance
PROJECT NARRATIVE Discrete evaluation of single cells using multi-parametric flow cytometric analysis has become the staple for interrogating immune cell properties, population frequencies, lineage commitment/differentiation and functional responses. The instrument serves to evaluate how changes in the immunoregulatory network of immune cell populations leads to large scale changes in immune responses, as described in the parent award. Knowledge gained from the use of this high-end instrumentation will help to resolve how pivotal activities in the molecular signaling pathway of immune cells govern differential immune responses in health and disease.